In vitro receptor and transporter assays for NIDA medications discovery and abuse liability testing

The National Institute on Drug Abuse (NIDA) is a United States federal government research institute whose mission is to "advance science on the causes and consequences of drug use and addiction and to apply that knowledge to improve individual and public health."